NICHD Neonatal Research Network (NRN)

PROJECT SUMMARY/ABSTRACT
This proposal is a renewal application from the Division of Neonatology at Nationwide Children’s Hospital (NCH)
and The Ohio State University (OSU) to participate with the Eunice Kennedy Shriver National Institute of Child
Health and Human Development (NICHD) under a cooperative agreement (RFA: HD-16-020) in an ongoing
multicenter clinical research program entitled the Neonatal Research Network (NRN). NCH/OSU was selected
in 2011 to become one of 18 academic centers of the NRN. In 2016, NCH/OSU along with an additional affiliated
neonatal intensive care unit (NICU) at Riverside Methodist Hospital (RMH) was again selected as one of the 15
centers that currently comprise the NRN. The Division of Neonatology has demonstrated a strong commitment
to the NRN and will continue to support and enhance this network. Pablo Sánchez, MD, Jonathan Slaughter,
MD, MPH, and Kristen Benninger, MD, MSc, are the Principal Investigator (PI), Alternate PI, and Follow-up PI,
respectively. Dr. Sánchez has extensive experience in the performance of multicenter, randomized clinical trials.
By being board certified in both Neonatology and Pediatric Infectious Diseases, he will provide expertise to the
NRN on issues in neonatal infectious diseases and antimicrobial stewardship, vexing problems in the NICU. Dr.
Slaughter has extensive experience in clinical research including clinical trial and advanced observational study
design, while Dr. Benninger studies the long term outcomes of opioid-exposed infants. The Specific Aim of this
proposal is to conduct multicenter clinical trials and observational studies in neonatal medicine in order to reduce
infant morbidity and mortality and promote healthy outcomes. With the strong support of the Pediatric
Department and Hospitals, NCH-OSU-RMH has the necessary academic and innovative clinical and research
infrastructure to ensure continued excellence in the performance of NRN studies. Our Neonatology Division has
a long-standing dedication to improving patient outcomes with a strong focus on health equity. We have
developed innovative signature clinical programs in extreme prematurity, bronchopulmonary dysplasia, infant
feeding, neonatal infectious diseases/antimicrobial stewardship, acute kidney injury, neonatal cardiology, and
neonatal neurology that have positively impacted patient outcomes and positioned us as a region-
al/national/international referral and consultation center. In addition, the Obstetric Dept. at OSU is one of 12
centers of the NICHD Maternal-Fetal Medicine Units (MFMU), and strong collaboration exists between the OSU
MFMU and NCH at all levels of clinical care and research. This ongoing partnership ensures a continued source
of diverse patients for clinical studies. NCH-OSU-RMH has a proven track record within the NRN, as evidenced
by its well organized clinical research program with a substantial percentage of eligible infants consented for
randomized trials and excellence in study conduct and data acquisition. Follow-up of study infants is integrated
within the large Follow-up Program at NCH, and follow-up rates of these infants remain excellent with substantial
departmental and divisional support.

Public health relevance
PROJECT NARRATIVE The Eunice Kennedy Shriver NICHD Neonatal Research Network (NRN) has been established to conduct multicenter, interventional, and observational clinical studies in neonates, including those who are preterm and of low birth weight. The goal of these studies is to reduce infant morbidity and mortality and promote healthy outcomes in high risk infants and children. The Division of Neonatology at The Abigail Wexner Research Institute at Nationwide Children’s Hospital (NCH) in collaboration with The Ohio State University (OSU) and its affiliated noenatal intensive care units has demonstrated a strong commitment to the NRN and remain committed to serve as one the network centers and enhance its productivity.